Role of dietary fatty acids in shaping lung macrophage homeostasis and inflammatory function

PROJECT SUMMARY
Obesity is a major modulator of lung immunity and is associated with poor outcomes in multiple inflammatory
lung diseases including asthma. Notably, the pathological features of obesity-associated asthma (OAA) are
distinct from non-obesity-related or “atopic” asthma: While atopic asthma is typified by type 2 inflammation and
eosinophilia, OAA is characterized by type 1 inflammation and neutrophilia, indicating a change in innate immune
activation with obesity. Yet, the underlying mechanisms by which diet-induced obesity alters innate immune cell
activation in the lung are unclear. Previous research demonstrated that diets high in saturated fat have
considerable effects on tissue-resident myeloid populations, including transcriptional and functional shifts toward
a metabolically activated state in adipose tissue. As saturated long chain fatty acids become more prevalent in
modern diets in the form of animal fats and preservatives, it is critical to determine their health consequences in
other tissues. The broad objective of this proposal is to decipher the effects of a saturated fat-enriched diet on
the lung in the steady-state and with an allergic stimulus. The central hypothesis is that the saturated 18-carbon
fatty acid stearate promotes cellular membrane rigidity and induces pro-inflammatory cytokine secretion in a
subset of lung-resident macrophages, which aggravates innate responses to an allergic airway challenge,
including exacerbated neutrophilia and worse pulmonary function. Aim 1 investigates the steady-state profile of
lung myeloid populations in mice fed normal chow or stearate-rich diets with or without myeloid-specific deletion
of the enzyme required for stearate incorporation into the membrane. The experimental approaches are 1) single
lung cell transcriptomic analysis for differentially expressed genes and gene sets and 2) flow cytometric cellular
phenotyping for inflammatory activation, myeloid infiltration, and cytokine production in the lung. Aim 2
determines the consequences of diet-induced inflammation in the lung in the context of an innate immune
challenge by leveraging a HDM/LPS model of OAA, assessing 1) protective effects of myeloid-specific deletion
of the stearate-processing enzyme, and 2) in vivo tests of pulmonary function in mice. Together, these studies
will provide insights into the impact of dietary saturated fatty acids on lung myeloid function and the development
of OAA, elucidating the role of metabolic activation and transcriptional shifts in innate immune responses, thus
paving the way for therapeutic interventions and a deeper understanding of the pathogenesis of obesity-related
lung inflammatory diseases. Conducted within the resource-rich, multidisciplinary environment of the Children’s
Hospital of Philadelphia, which is committed to training the next generation of scientific leaders, support of this
proposal positions the fellow to gain comprehensive skills in immunology, metabolism, and advanced research
methodologies. The proposed research strategy and training plan will foster critical thinking, leadership abilities,
and scientific innovation, paving the way for the fellow's transition to an independent research career dedicated
to addressing complex health challenges.

Public health relevance
PROJECT NARRATIVE The proposed research investigates the interplay between dietary saturated fat-induced alterations in immune cell function and allergic inﬂammation, with a focus on tissue-resident macrophages (TRMs) and other myeloid cells in the lung. Understanding how dietary fatty acids modulate myeloid functions holds signiﬁcant promise for unraveling the mechanisms driving obesity-associated asthma (OAA), a condition causing an estimated one million preventable asthma cases annually. These insights will pave the way for targeted interventions by identifying candidate pathways for dietary and pharmacological interventions to mitigate obesity-related immune dysregulation and associated respiratory ailments, ultimately aiming to alleviate the burden of obesity on public health.